Rapid Point-of-Care Detection of T. pallidum Resistance to Macrolides and Tetracyclines by Multiplexed Loop-mediated amplification (LAMP)

ABSTRACT [30 lines]
The continued growth of syphilis cases in the United States is associated with signiﬁcant maternal-fetal
morbidity and mortality, health disparities for racial/ethnic minorities, and men who have sex with men (MSM).
Rising case counts have led to a shortage of penicillin, the treatment of choice for the etiologic agent of syphilis,
Treponema pallidum subsp. pallidum, and the only approved therapy for pregnant patients and neonates. Penicillin
shortages have led to increased reliance on doxycycline for treatment and prophylaxis, but patient compliance
is suboptimal, particularly for doxycycline treatment which requires twice daily dosing for > 14 days. These
conditions - high case counts, increased use of doxycycline, and potential incomplete treatment – are ripe for
selection of doxycycline resistant T. pallidum strains. A previous second line treatment, single dose azithromycin,
is no longer recommended due to high rates of resistance (> 79%) observed among MSM. However, susceptible
strains may circulate among non-MSM populations where resistance rates have historically been much lower
(11%) suggesting there are still patients who could beneﬁt from azithromycin therapy. Unfortunately, there are
no clinical assays that detect T. pallidum resistance to either drug. Such assays would serve the dual purposes of
public health surveillance and informing therapeutic antibiotic selection, particularly for patients
unlikely/unable to comply with multiday doxycycline treatment. Resistance to azithromycin is mediated by
single nucleotide polymorphisms (SNPs) in the 23S rRNA gene and doxycycline resistance is predicted to
emerge as SNPs in the 16S rRNA gene. Resistance-conferring SNPs are amenable to molecular detection by
allele-speciﬁc nucleic acid ampliﬁcation assays. We have previously developed and validated in our clinical
laboratory a sensitive and speciﬁc Reverse-Transcription Loop-mediated isothermal Ampliﬁcation (RT-LAMP)
molecular test for T. pallidum and are currently validating the assay in a multiplexed, point-of-care (POC) format.
In this project, we propose to build upon our existing assays by developing complementary approaches to detect
antibiotic resistance in T. pallidum. The deliverables will be a POC allele-speciﬁc LAMP for drug resistance (AS-
LAMP) multiplexed with organism detection and an internal ampliﬁcation control, and a parallel next-
generation sequencing (NGS) assay for high-complexity clinical laboratories. In Aim 1, we propose to develop
and validate both a POC AS-LAMP and an amplicon-NGS assay for detection of SNPs mediating azithromycin
resistance. In Aim 2, we propose to develop and validate an amplicon-NGS assay for detection of doxycycline
resistance and to develop a panel of AS-LAMP primers that can be deployed following detection of emerging
doxycycline resistance genotypes. After primer and protocol optimization, we will validate the assays following
established procedures for deploying clinical assays in CLIA- and CAP-certiﬁed laboratories. Our goal is to
generate inexpensive, rapid POC testing for T. pallidum drug resistance to guide optimal therapy during a single
patient encounter and to improve public health surveillance for drug resistant strains.

Public health relevance
PROJECT NARRATIVE Rising syphilis cases have led to shortages in the treatment of choice ‐ single‐dose intramuscular penicillin – leading to increased reliance on multiday therapy with doxycycline, since high rates of drug resistance preclude use of azithromycin as an alternative single‐dose therapy. This proposal outlines development and validation of two complementary types of molecular tests to detect genotypic determinants of drug resistance to azithromycin and doxycycline which could be applied at the point of patient care to inform antibiotic therapy and for public health monitoring of emerging doxycycline resistance. The point‐of‐care strategy will develop an allele‐speciﬁc variant of a rapid, Loop‐mediated isothermal ampliﬁcation (LAMP) assay developed by our laboratory to detect Treponema pallidum, the etiologic agent of syphilis; a second, complementary approach will develop an amplicon‐next‐generation sequencing assay for detection of T. pallidum drug resistance in the clinical laboratory.